Brain-based biomarkers of restricted and repetitive behaviors in toddlers at risk for autism

Abstract
Autism spectrum disorder (ASD) affects one in 44 children.
1 Early diagnosis is critical for optimizing
outcomes, yet children are not typically diagnosed until 4 years of age.2 In concert with early behavioral signs,
early neural markers could identify toddlers at risk of developing ASD to aid earlier diagnosis and targeted
interventions. Neuroimaging studies have primarily examined structural brain abnormalities in toddlers at high
risk of developing ASD3. A growing body of work provides evidence for functional brain network connectivity
alterations in older children with ASD (7-12 years of age).4 While innovative dynamic functional magnetic
resonance imaging (fMRI) methods reveal candidate brain networks of dysfunction underlying the heterogeneity
of the disorder and symptom severity in older children with ASD,567,8no study to date has evaluated the relationship
between brain network dynamics and behavioral outcomes in toddlers with ASD. Restricted and repetitive
behaviors (RRBs), core symptoms of ASD,9 are particularly understudied. The goal of this project is to identify
early functional brain biomarkers of ASD and brain-behavior relationships with RRB outcomes across mixed
clinical and typically developing (TD) groups. This study will utilize a dataset previously collected by the UCSD
ACE Center comprised of toddlers (12-36 months, n = 231) who were identified as either TD or at-risk for a
developmental disability using an early screening form (Communication and Symbolic Behavior Scales
Developmental Profile; CSBS-DP).10Some toddlers were later diagnosed with ASD (n = 89), TD (n = 70), other
diagnosis (n = 72; Language Delay, Developmental Delay, and Autism Features). Since the sample includes
multiple diagnostic groups, this dataset offers a unique opportunity to examine early brain biomarkers for ASD
and RRBs across diagnostic categories, as envisioned by the Research Domain Criteria (RDoC) approach.11
Early behavioral indicators alone do not always clearly indicate which children will go onto to develop ASD.12 The
results from this study may lead to the development of reliable biomarkers to identify children at risk for ASD in
concert with overt behavioral signs of the disorder. Neural biomarkers of ASD and RRBs will in turn lead to earlier
and more efficient diagnosis and treatments. This work builds upon the applicant’s previous research experience
at the UCSD ACE Center collecting neuroimaging data from toddlers.13 The applicant has previously examined
dynamic brain biomarkers of RRB symptoms in older children with ASD (8-12 yo),7,14–16 reviewed the brain
biomarker literature in toddlers with ASD,3analyzed large lifespan neuroimaging datasets (n = 601), and gained
a foundation in statistics and clinical neuroscience. Through formal coursework and individual meetings, the
applicant plans to engage in four major areas of training: (1) cutting-edge analyses to assess brain dynamics
using functional neuroimaging data, (2) sophisticated statistical approaches for modelling longitudinal data, (3)
considerations for conducting research with young children at risk for autism, and (4) career development.

Public health relevance
Project Narrative Children with autism spectrum disorder (ASD) are not typically diagnosed until 4 years of age and therefore miss a critical developmental time period important for optimizing outcomes. A core symptom of ASD is restricted and repetitive behaviors (RRBs), which impair daily functioning and impact all aspects of social and cognitive development. This proposal will explore early life brain-based biomarkers for ASD and RRBs and has the potential to improve the lives of diagnosed children and their families while providing an opportunity for the applicant to learn crucial skills necessary for an independent career as a developmental cognitive neuroscientist.